Bioengineering Center for Regeneration and Formation of Tissues (SC BioCRAFT)

This COBRE Phase III application is aimed at sustaining the research infrastructure built during the first ten years
of NIGMS funding. Our COBRE “South Carolina Bioengineering Center for Regeneration and Formation of
Tissues” has become a nationally recognized, collaborative center with unique strengths in bioengineering
approaches to regenerative medicine. Three underlying themes define the Center's research: advance
biomaterial design and application; in situ tissue repair with targeted therapies; and applying the principles of
normal developmental biology to regenerative medicine or stem cell based tissue engineering. SC BioCRAFT
accomplishments towards these three translational goals include the recruitment of 10 new faculty, mentoring
and training of 23 COBRE target faculty, and the development of two research core facilities. Programmatic
outcomes include 26 independent NIH research awards, 62 research awards from other agencies to target
faculty, and >550 peer reviewed publications. South Carolina Centers of Economic Excellence: SmartState
awarded three endowed chairs in Regenerative Medicine and Advanced Tissue Biofabrication in partnerships
with Clemson and the University of South Carolina. SC BioCRAFT participated in the successful renewal of a
statewide INBRE award with a focus on bioengineering/regenerative medicine.
For this P30 application, the plan transitioning to independence of NIH/NIGMS support during the next five years
is to enhance and upgrade our core technologies, to increase their competitiveness, to attract greater usage
(and cost recovery), and to promote new research collaborations with our Center that can lead to submission of
competitive research applications and broaden our statewide outreach, especially to other IDeA centers. A seven
step, five-year strategic plan including implementing fee structures, pilot projects/voucher program, outreach
activities and programmatic development is proposed to sustain the SC BioCRAFT/COBRE center and its
scientific cores (Biomaterials Engineering and Testing and Translational Research Imaging). The founding
director of Clemson's SC BioCRAFT COBRE will lead the Administrative Core and will be assisted by two
outstanding scientists from Medical University of South Carolina who have themselves directed COBREs.
Together, these three leaders will act as the main operational arm of the Center. An External Advisory Committee
will provide ongoing assessment and evaluation of the Center's progress. Institutional commitments from the
Vice President for Research, ~2 million dollars, will help ensure programmatic growth development and long-
term sustainability of the Center.

Public health relevance
The overarching theme of the Bioengineering Center of Regeneration and Formation of Tissues (SC BioCRAFT) is tissue regeneration, which is highly relevant to NIH’s mission of applying fundamental knowledge about the nature and behavior of living systems to enhance health, lengthen life, and reduce illness and disability. As the nation’s only bioengineering COBRE center, we are currently supporting projects and cores to find novel methods to restore or regenerate diseased neural, cardiovascular, and bone tissues.